Compartimental bi-specific antibody and cytokine therapy for advance desmoplastic small round cell tumors

Project Summary
Overall response to the epidermal growth factor receptor (EGFR) inhibitor cetuximab is poor and resistance,
both intrinsic and acquired, is a critical issue. Therefore it is imperative to elucidate the mechanisms of poor
response to cetuximab and develop strategies to enhance tumor response to cetuximab and improve patient
outcomes. My overall research interests center around inflammation and immune response as key
mechanisms of tumor progression in HNSCC patients and poor tumor response to cetuximab. My dissertation
research focuses on the IL-1 pathway as an important player in tumor response to cetuximab in HNSCC
patients and the overall hypothesis of my dissertation research is that IL-1 blockade will improve the anti-
tumor efficacy of cetuximab in HNSCC. Findings from my dissertation research project thus far strongly
support this hypothesis indicating that IL-1 blockade using a neutralizing IL-1 alpha (IL-1α) antibody increased
HNSCC tumor response to cetuximab in xenograft mouse models and that IL-1α may be an important
biomarker to predict tumor response to cetuximab for HNSCC patients. For the remainder of my dissertation
research project, I will continue to test my hypothesis using the FDA approved IL-1 receptor antagonist (IL-
1RA) anakinra in combination with cetuximab in HNSCC mouse models, and assess potential mechanisms of
tumor response to combination drug therapy. Finally, during my postdoctoral period I am interested in
combining anti-IL-1 therapy with anti-CTLA4/PD1 therapy for HNSCC since the current trend in cancer therapy
including HNSCC is to activate the immune system using anti-CTLA4/PD1 therapies. Overall, I believe that this
F99/K00 award will assist me in establishing my research career focused on inflammation and immune
response as important players in tumor response to drug therapy and pave the way for me to become a
successful independent investigator.

Public health relevance
Project Narrative Poor tumor response to the EGFR inhibitor cetuximab is a critical issue for the effective treatment of HNSCC patients. The current proposal will focus on inflammation and immune response as key mechanisms of tumor progression in HNSCC patients and poor tumor response to cetuximab. Overall, I believe that this F99/K00 award will assist me in establishing my research career focused on inflammation and immune response as important players in tumor response to drug therapy and pave the way for me to become a successful independent investigator.